The Role of Hemocytes in tick Rickettsia parkeri infection

Summary
Tick-borne diseases, including Spotted Fever Group Rickettsiosis, are rising due to climatic
changes and are predicted to increase. The increase in rickettsiosis is a significant threat to public
health in the absence of preventive measures. Tick hemocytes (immune cells) are mammalian
leukocytes' functional equivalent and limit ticks' capacity to transmit human pathogens through
phagocytosis, encapsulation, secretion of immune factors, and immune priming. The ixodid ticks
rely on an efficient innate immune system for protection against invading microbes, in which
hemocytes play a crucial role. Tick cellular immunity is primarily a neglected and unexplored field
of vector biology. A complete understanding of the immune factors involved in the interactions
between ticks and tick-borne pathogens in hemocytes is crucial to elucidate their role in vector
competence and to help identify novel targets for developing new strategies to block pathogen
transmission. This study aims to build technologies by realizing the potential of exploiting tick
hemocyte biology. We began addressing this need, and our compelling preliminary data show the
immune cell types and complexity in the uninfected and Rickettsia parkeri-infected ticks. Bulk
RNA-seq analysis of uninfected and infected tick hemocytes showed that out of 39,429 coding
sequences, 7.3% were differentially expressed and classified as related to immune genes. We
hypothesize that Rickettsia parkeri manipulates the Amblyomma maculatum phagocytic immune
cells to facilitate systemic dissemination and enhance vertical transmission. To address these
questions, we will examine Amblyomma maculatum immune cell populations from uninfected and
infected (Rickettsia parkeri-infected) conditions through the following specific aims: 1) To
generate single-cell RNA sequencing from uninfected and Rickettsia parkeri-infected hemocytes
for downstream analyses, and 2) To dissect the role of hemocyte-specific marker genes in cellular
immunity and vector competence by RNA interference approach. In this high-risk, high-reward
application, these aims will provide critical reagents, tools, and data to address critical gaps in
fundamental knowledge of tick immune cell biology and vector competence. These studies will
provide critical data to address gaps in fundamental knowledge of tick immune cell biology and
vector competence. This exploratory project will also provide an opportunity to develop new tools
to study hemocyte biology. Additionally, the outcome of this project could be extrapolated to other
tick species of public health significance and is expected to provide a critical comparative
understanding of invertebrate immunology.

Public health relevance
PROJECT NARRATIVE Tick-borne diseases are on the rise due to climatic changes and are predicted to increase. The increase in tick- borne diseases poses a significant threat to public health in the absence of preventive measures. This project aims to identify tick immune cells (hemocytes) subtypes with distinct molecular signatures and validate these characterizations using various bioinformatics and experimental molecular tools.